Integrating AI nowcasting models with digital communications to reduce RSV infections in rural areas

Project Summary/Abstract
Public Health 3.0 places an emphasis on the use of innovative technologies for improved community
engagement as well as an increased use of rigorous and timely data in order to deliver relevant health
messages (1). This priority also aligns with that National Institute on Nursing Research’s (NINR) research
lenses focused on reducing health disparities, advocating for prevention and health promotion, and integrating
elements of SDOH to advance innovative new systems (2). Among pediatric populations, respiratory syncytial
virus (RSV) poses a serious, yet preventable threat. Educational campaigns known to be effective among rural
communities are currently hamstrung by hard-to-reach residents, limited data-driven techniques, and
availability of resources (4,17).
Grounded in previous work (56-59), Social Cascade enables trusted community messengers (e.g.,
pediatricians) to share reliable, accurate health-related content on popular social media channels–the #1
source for health information among younger generations regardless of broadband subscription (6,38,70).
However, health messaging is most effective when it is tailored to a specific community and timed accordingly
(12,13,30). As seen in prior work (56-59), hybrid machine learning techniques and composable diffusion
models afford promise for dynamically reconciling masses of data sources. In turn, such algorithms can
accurately predict RSV infection rates (also known as nowcasting) for a particular community and ensure
the right message is being delivered to the right audience at the right time (61-65). Using both temporal and
spatial dimensions, interventions have to be proven successful for promoting behavioral change among rural
populations for vaccine uptake (64,66) and infectious disease prevention strategies (36).
This Phase I proposal will build and operationalize a tailored Spatio-Temporal Nowcasting Model (STNM) to
enhance health communications distributed via social media. The novel integration of these elements holds
strong theoretical promise for promoting behavioral change and reducing RSV infection rates in the target rural
population of eastern NC. Specifically, the plan seeks to answer 1) can the STNM accurately predict RSV
outbreak in real time, and 2) does Social Cascade’s data-driven content and delivery system positively impact
behavioral change related to the prevention of RSV infections in the target community?
As of April 2024, Social Cascade has acquired 65 customers who have posted more than 6,400 pieces of
content reaching more than 500,000 families with a total of 26,935 post engagements (e.g., likes, shares,
comments). Parents are enjoying the content with 89.3% of Social Cascade posts earning an engagement rate
(number of post engagements as a function of views) above the industry standard of 5%. Furthermore, the
underlying framework has far reaching impact potential as it easily extends to additional health priorities and
population segments aligning to the NINR’s Strategic Plan (2).

Public health relevance
Project Narrative This project leverages proven behavioral change interventions and data-driven community insights to more effectively deliver health messages aimed at reducing health disparities among rural communities. Social Cascade is a first-to-market health literacy solution enabling healthcare providers to maintain an active social media presence filled with credible, reliable information to connect with and support patients and their families throughout the year. Through this project, Social Cascade seeks to apply state-of-the-field AI and machine learning techniques for effectively delivering patient education related to reducing RSV infections, and, ultimately, operationalize the solution at scale.